HERCULES: Exposome Research Center

HERCULES: ADMINISTRATIVE CORE – SUMMARY
The Administrative Core (Admin Core) functions to support and develop critical leadership, organizational, and
identity roles for the HERCULES: Exposome Research Center. Through funding, mentoring, outreach,
communication, educational, and scientific resources, the Core promotes the Center’s vision of serving as an
intellectual hub in the advancement and translation of exposome research to improve human health. The
Admin Core’s Executive Committee will assure the close integration of the cores and programs of the Center
and will promote the exposome theme and translational environmental health research framework to Members,
stakeholders and community partners. Through comprehensive evaluation and feedback from Members and
an Internal Advisory Board, External Advisory Board, and Stakeholder Advisory Board, the center will seek to
continuously improve its operation and services to confirm that the Center mission to learn how the exposome
affects health and community well-being and using that knowledge to improve human health is being met. To
meet all aspects of our Center vision, the Admin Core has outlined and will pursue the following Aims: (Aim 1)
Promote the HERCULES scientific vision through a supportive Center structure; (Aim 2) Support the
HERCULES mission through coordination and integration of HERCULES research and activities; (Aim 3)
Effectively manage Center resources through tracking and evaluation; (Aim 4) Oversee the recruitment,
appointment, evaluation, termination, training, and development of Center Members; and (Aim 5) Facilitate
interactions with HERCULES partners. By aggressively pursuing the above Aims, the Admin Core will assure
that HERCULES remains on its path of excellence by providing a combination of inspirational vision, scientific
oversight, fiscal management, resource allocation, and critical evaluation of ongoing and future activities.